Microbiome and AD/ADRD Risk in SOL

Project Summary/Abstract
Alzheimer’s disease and related dementias (AD/ADRD) is a growing public health burden, further accentuated
by the rapid aging of the US population and increased life expectancy. The gut microbiome, sometimes called
the ‘second brain’ engages in bi-directional communication with the Central Nervous System (CNS) and is
thought to contribute to neurodegeneration and AD/ADRD risk. The microbiome is dynamic, responsive to
external stimuli and modifiable, creating the possibility for AD/ADRD prevention and treatment. Prior human
studies on GMB and ADRD have had limitations such as cross-sectional design, small sample size, and lack of
detailed GMB characterization. Notably few GMB and no GMB – AD/ADRD studies have focused on Latinos,
a high-risk population, with distinct GMB profiles and over double the risk of AD/ADRD compared to non-Latino
Whites.
The proposed project will elucidate the microbial origins of AD/ADRD in SOL and examine whether the
microbiome is a potential mechanism that links diabetes and AD/ADRD risk. We will use the SOL cohort’s
AD/ADRD sub-study, which over ~15 years followed 6,377 individuals with longitudinal cognitive function
assessments, structural brain MRI, plasma amyloid, Tau, and neurodegeneration (ATN) biomarkers (amyloid
beta [AB40-42], p-tau181, neurofilament light chain [NfL], glial fibrillary acidic protein [GFAP]), and plasma
metabolomics. GMB metagenomic profiles are available among 2204 participants and longitudinal stool
metagenomic and serum metabolomic profiles will be generated by this study. The study will benefit from
careful assessment of key microbiome covariates, notably, medication, diet, anthropometric variables, physical
activity, social and psychosocial factors. The proposed work will pave the path for GMB-based early detection,
prevention and/or treatment of AD/ADRD among high-risk Latinos.

Public health relevance
Project Narrative Few prior studies of the microbiome and AD/ADRD have focused on Latinos, a disadvantaged population with a high burden of diabetes. This study will examine how the microbiome impacts AD/ADRD risk in a large Latino cohort, and the role of the microbiome in the diabetes-AD/ADRD relationship. The project will contribute to the understanding of mechanisms driving AD/ADRD risk in Latinos, and has potential to improve future precision medicine for preclinical diagnosis and/or treatment of AD/ADRD in high-risk populations.